Photoinduced, Copper-Catalyzed Substitution Reactions of Alkyl Electrophiles by Nitrogen Nucleophiles

Abstract Not applicable. Please refer Research Strategy page for parent grant abstract.

Public health relevance
Narrative Equipment Administrative Supplement - Not applicable